The Role of Platelets in Cancer Cachexia

SUMMARY
Cancer cachexia is a complex metabolic syndrome characterized by muscle wasting, weight loss, and decreased
quality of life. Patients with cancer cachexia experience impaired muscle function, reduced treatment tolerance,
and lower survival rates. Despite progress in understanding the condition, its underlying mechanism and high
mortality rate remain unclear. The proposed research aims to investigate the role of platelets in cancer cachexia
development, as they are involved in inflammation and tissue wasting. Preliminary data suggest an association
between elevated platelet counts and the pre-cachexia stage and platelet activation and severe/refractory
cachexia. The proposed study hypothesizes that platelets play a crucial role in the recruitment of immune cells
and the release of pro-cachectic factors, ultimately leading to muscle loss. The research will test the hypothesis
through two aims: depleting platelets at pre-cachectic stages to assess the impact on inflammation and muscle
wasting and examining the effects of activated platelets on muscle wasting in cancer and chemotherapy-induced
cachexia. The project aims to provide novel insights and potential approaches by targeting platelets in cancer
cachexia.

Public health relevance
NARRATIVE The impact of this project lies in advancing the understanding of platelet involvement and significance in cancer cachexia. By targeting platelets in the context of cancer cachexia, this research will provide novel prognostic and therapeutic insights, moving the field forward in a new direction.